Digitally Prompted Parenting: A Text Message Parent-Based Alcohol Intervention for Incoming College Students

Project Summary
Drinking remains a significant public health concern on college campuses with the transition into and first
months of college identified by NIAAA as a critical high-risk period. Contrary to popular belief, parents can
play a significant role in mitigating alcohol-related risk during this period by maintaining communication with
their underage emerging adult children and expressing less permissive attitudes toward alcohol use. Trials of
existing Parent-Based Interventions (PBIs) which target parents’ communication and attitudes toward
underage drinking delivered during the summer months prior to entering college have found modest effects on
student drinking outcomes; however, these interventions are less effective when financial incentives are not
provided to parents for participation. One explanation for this is that time and effort required to complete
these programs pre-matriculation may be too demanding. A solution to this problem is to reduce the amount of
effort required from parents’ pre-matriculation and provide them with simpler tasks that could be completed
throughout the first semester, such as sending their student risk-reducing text messages. Findings from our lab
indicate that maintaining communication during the first few weeks of college via text message can help to
prevent increases in alcohol use and consequences throughout the first year of college. Our preliminary pilot
work also suggests that there could be benefits to delivering text messages from parents to students stressing
less permissive attitudes toward drinking on the nights when students are going out, and having parents ask
students to check-in at the end of the night might reduce drinking even more. Given these findings, this
proposal addresses limitations with existing PBIs by developing the first text message PBI (tm-PBI) that will
deliver carefully timed, brief, tailored text messages to parents prompting them to send risk-reducing text
messages to their child that are informed by theory, literature, and parent feedback. In Phase 1, we will design,
develop, and optimize the tm-PBI, Digitally Prompted Parenting (DPP) (AIM 1). DPP includes a web platform
that includes features such as embedded videos and surveys, profile management, and an interactive calendar
module. More important, the platform permits the research team to edit, automate and track the delivery of
tailored text prompts based on information provided by parents on the platform (student sex, parent sex,
race/ethnicity, and parent attitudes toward drinking). Phase 1 will also include focus groups with parents of
first-year students aimed at identifying ways to tailor text message content (N=80). We will the functionality of
the fully operable DPP with a subset of this sample (N=16) to identify and resolve any bugs affecting program
performance. In Phase 2, we will conduct a pilot RCT with 300 parent-student dyads to evaluate shorter- and
longer-term effects of DPP on first-year drinking relative to an active control condition (AIM 2). Finally, we will
assess the acceptability/feasibility of the DPP program (AIM 3) via engagement data within the web platform
and by surveying parents from the DPP condition (N=150), informing further iterations of the DPP program.

Public health relevance
Project Narrative The proposed project develops and evaluates the efficacy of Digitally Prompted Parenting (DPP), a text- message parent-based intervention (PBI) for parents of incoming college students that is designed to prevent heavy episodic drinking and the development of risky drinking behavior that often occurs in the first semester in college. Unlike existing PBIs which are delivered before students arrive on campus, DPP leverages existing parent-student communication via texts prompting parents to send tailored risk-reducing messages on days and times when alcohol use is common among college students. The brevity of text messages and the simplicity of the task that parents are asked to engage in makes DPP cost-effective and easy to disseminate, while increasing the likelihood that parents engage with and implement the intervention content in a way that translates into stronger effects on drinking relative to the more demanding and time-consuming standard PBIs.